Cell type-specific gene therapy approach for TOMT-linked congenital hearing loss

PROJECT SUMMARY/ABSTRACT
Hearing loss is one of the most prevalent sensory deficits, yet there are no FDA-approved biological therapies.
There are over 100 distinct forms of nonsyndromic genetic hearing loss, each caused by mutations in different
genes. Advances in adeno-associated viral (AAV)-based gene therapies for Otoferlin-linked genetic hearing loss
have shown great promise for translating therapeutics developed in mouse models to humans. However, many
challenges exist, and most gene therapies lead to incomplete hearing restoration and may cause side effects.
Namely, the cochlear expression patterns and levels, and the structural and functional impacts of deafness-
linked mutations are gene- and cell-type-specific. Thus, a one-size-fits-all approach is not optimal for hearing
loss gene therapies, and the development of precision, cell-type-specific therapies is an essential unmet need.
To establish a cell-type-specific, precision medicine approach for maximal therapeutic benefit and minimal
adverse effects, we formed Echogenesis Therapeutics. We used a computational approach with in vivo
screening of candidates to generate candidate cell-type-specific genomic promoter fragments for precise
therapeutic expression. Using this platform approach, we discovered a novel promoter that is highly specific
for cochlear hair cells. Here, we present proof-of-concept of our platform for the development of our first target
cell-type-specific therapy for congenital genetic hearing loss. Mutations in TOMT/LRTOMT/COMT2 (TOMT)
cause profound hearing loss in humans—0.5% to 8% of all cases of genetic hearing loss, depending on the
population sampled. Mouse models with Tomt mutations faithfully recapitulate the human hearing loss
phenotype. Consistent with our hypothesis for the need for cell-type-specific gene therapies, we found that inner-
ear delivery of TOMT driven by gene therapies utilizing promoters currently used for hearing loss gene therapy
led to significant hearing loss, as evidenced by elevated auditory brainstem response (ABR) thresholds in normal
hearing mice. Using our novel hair-cell-type-specific promoter, we found that our cell-type specific approach: 1)
is much more specific for hair cells than other promoters; 2) significantly restores ABR thresholds in congenitally
deaf Tomt mutant mice; and 3) does not cause hearing deficits in normal hearing mice, in contrast to other
therapies. This STTR Phase I project will address the efficacy of our AAV-based cell-type-specific gene therapy
expressing human TOMT in congenitally deaf Tomt mutant mice for hearing restoration. Specifically, we will 1)
determine effective gene therapy dosages for hearing restoration; 2) determine the timing window for therapeutic
intervention; and 3) determine the duration of the therapeutic benefit. Overall, our findings will have significant
implications for patients with hereditary hearing loss, including those with TOMT mutations, and broader impacts
toward improving the understanding of cell-type-specific delivery in the cochlea. Importantly, our proposed cell-
type-specific approach will be also relevant for other forms of hearing loss with a gene-related etiology or genetic
predisposition, such as noise-induced and age-related hearing loss, and for vestibular disorders.

Public health relevance
PROJECT NARRATIVE Although hearing loss is a highly prevalent sensory deficit, there is a significant lack of FDA-approved biological therapies. We founded Echogenesis Therapeutics to establish a cell-type-specific, gene-therapy-based precision medicine approach for hearing loss, aiming to enhance therapeutic efficacy and minimize adverse effects. This STTR Phase I application will advance the efficacy of our viral-based cell-type-specific gene therapy for hearing restoration in congenitally deaf mutant mice, which will have significant implications for patients with hereditary hearing loss and contribute to a better understanding of cell-type-specific delivery in the cochlea.